Restoring Dexterous Hand Function with Artificial Neural Network-Based Brain-Computer Interfaces

Project Summary/Abstract
Intracortical brain-computer interfaces (iBCIs) are promising solutions for restoring function to people with
paralysis with orders of magnitude greater performance than their non-invasive analogs. Present iBCIs monitor
the user’s brain signals and use a decoding algorithm to map the measurements from the brain directly to
external variables, such as computer cursor velocity. People with tetraplegia have indicated that restoring hand
function is their highest priority, however, current hand-focused iBCIs are unable to match the capabilities of the
native human hand in terms of the number of independently-controlled fingers, the quality of the control, and the
simultaneous use of the fingers with movements of the arm. These limitations hinder the widespread clinical
deployment of hand-focused iBCIs.
Recent studies have shown that much of the activity in motor cortex does not directly correspond to
movement variables (like finger angles), but instead serves an internal, computational role to reliably generate
motor outputs. Neural population dynamics, which are rules that govern the evolution of neural population activity
over time, can be used to more accurately parse movement- and computation-related activity in motor cortex.
Dynamics-based decoders first model the dynamics driving recorded neural activity, then use a decoder to map
the estimated dynamics to movement. Dynamics-based decoding has already improved iBCI performance for
predicting the arm movements of monkeys by 36%, but it remains unknown how well dynamics-based decoding
can predict the movements of human fingers.
The objective of this proposal is to restore dexterous finger control with an iBCI in people with paralysis.
The central hypothesis is that dynamics-based decoders will bridge the gap in capabilities between hand-focused
iBCIs and able-bodied hand function. The rationale for the proposed research is that the performance
improvements introduced by dynamics-based decoders will translate from predicting arm movements to
predicting finger movements. The hypothesis will be tested with people with upper extremity paralysis through
the following two specific aims: 1) increasing the number of independently-controlled fingers of a robotic hand
without sacrificing control quality, and 2) maintaining performance of controlling dexterous finger movements
while simultaneously controlling movements of the entire robotic arm. The dynamics-based decoders will use
state-of-the-art artificial neural networks (ANNs)-based dynamics models to achieve the best estimate of the
underlying dynamics paired with ANN-based dynamics decoders to translate the estimated dynamics into
movement. The dynamics-based decoders will be compared against direct decoders that have been traditionally
used in human iBCIs. This work may be the first step toward providing people with paralysis a general-purpose
iBCI-controlled robotic arm to assist them with independently completing activities of daily living at home.

Public health relevance
Project Narrative Intracortical brain-computer interfaces have extraordinary potential to restore full upper extremity function to people with paralysis, but current solutions fall short of the capabilities of able-bodied people. Recent studies have shown drastic improvements predicting motor intention when using decoding algorithms that model neural population dynamics – the rules governing the evolution of neural activity over time – instead of directly decoding the recorded neural activity. This research proposal aims to use dynamics-based decoding to bridge the gaps in performance between intracortical brain-computer interface-controlled hands and able-bodied hands, creating a general-purpose upper extremity prosthesis to restore independence to people with paralysis.